Conserved Element DNA Vaccine

An ideal HIV vaccine should provide protection against all HIV-1 variants. Thus, an important aspect of HIV vaccine development is the selection of immunogens, which has to be taken into consideration, the diversity of the different HIV clades and the identification of the critical epitopes able to induce relevant immune responses, avoiding potential immunodominant "decoy" epitopes. Considering the diversity of the different HIV clades, we are focusing on highly conserved regions of HIV to induce immune responses to nearly invariable proteome segments, essential for the function of the virus, while excluding responses to variable and potentially immunodominant "decoy" epitopes (Kulkarni, PLoS One 9: e86254, 2014; PLoS One 9: e111085, 2014; Hu, Hum. Vaccin. Immunother. 14: 2163, 2018). In proof-of-concept studies in mice and macaques, we demonstrated that immunization with Gag CE DNA elicits robust cellular and humoral immune responses including robust cytotoxic T cell responses targeting subdominant epitopes against CE, which cannot be achieved by vaccination with the full-length p55gag DNA. Priming with CE DNA and boosting with CE+gag DNA maximizes both magnitude and breadth. This DNA vaccine regimen induces potent memory responses that can be rapidly recalled ~2 years later by CE DNA booster vaccinations (Hu, Hum. Gene Ther. 29: 1029, 2018). Thus, we identified a novel and effective strategy to maximize responses against Gag and provide a novel strategy to shift the immunodominance hierarchy and to induce robust immune responses to subdominant epitopes, effectively targeting the Achilles' heel of the virus. We further developed an SIV homolog of the CE and demonstrated that priming with CE DNA followed by CE+gag DNA booster vaccination significantly increased cytotoxic T cell responses to subdominant highly conserved Gag epitopes and maximized response breadth (Hu, J. Immunol. 197: 3999, 2016). These data mirror our findings from the HIV p24CE vaccine and provide us with a tool to explore the functional applications of the Gag CE DNA vaccine in the macaque model. SIV Gag CE-specific T cells were correlated with reduction of viral infection. Application of this CE DNA vaccine is expanded to our on-going therapeutic vaccine trials in the macaque model. We have translated the HIV CE DNA vaccine concept to the clinic in the HIV Vaccine Trial Network (HVTN)/DAIDS/NIAID-supported clinical trial (HVTN 119; NCT03181789) with the aim to test whether our p24CE DNA vaccine concept elicits superior breath and magnitude of Gag responses compared to the optimized immunogen comprising the complete p55Gag protein (Kalams, JCI insight: 9:e180819, 2024). This vaccine included Profectus' GENEVAX IL-12 DNA as molecular adjuvant and in vivo electroporation as DNA delivery method, the two vaccine components our research had shown to be of importance to induce potent T cell responses in macaques. HVTN 119 combines several of milestones (DNA expression vectors, adjuvants, and delivery) we have achieved over many years in vaccine development. In 2nd trial, we have translated the Gag CE DNA vaccine in a phase I/IIb trial (ACTG A5369; NCT03560258) supported by the AIDS Clinical Trial Group, tested in HIV-infected persons under HAART (Jacobson, AIDS 38: 963, 2024;). Together, HVTN119 and A5369 allowed us to explore the translation of our data from mice and macaques to humans and initial data analysis supports our achievement of this goal. Both trials have demonstrated that the p24CE DNA vaccine is safe and immunogenic in humans. We achieved our goal to translate results from pre-clinical trials to humans and found that inclusion of the CE immunogen contributed significantly to direct immune responses to these highly conserved regions. These two trials offer further another unique opportunity to directly compare the same vaccines in two different cohorts, naive and HIV-infected on ART, using the same methodology, and will provide novel insight in the development in immune responses comparing the two cohorts. In addition, the CE DNA vaccine regimen has been tested in a third trial (NCT04357821) supported by amfAR and UCSF as part of a combinatorial therapy to induce an HIV remission (Peluso, Res Sq. 2025. PMID: 40166020). This trial showed that the majority of the participants who received combination immunotherapy exhibited virologic control post-ART, indicating that the treatment mediated immunological and virological control. Importantly, robust expansion of activated CD8+ T-cells early in response to rebounding virus correlated with lower viral load set points. Thus, our CE DNA vaccine successfully induced critical CD8 T-cell responses and our current research aims to further improve this. We have recently identified a novel DNA nanoparticle vaccine platform able to more efficiently induce highly cytotoxic CD8 T-cells. We are in the process of testing this regimen for the CE vaccine towards developing a next generation clinical trial. Together, our data are in support of our goal is to develop and test immunotherapeutic methods that can lead to virus reservoir reduction or elimination. Our studies have provided useful information about nucleic acid vaccine platforms and is guiding further clinical development. In on-going studies, we are further developing treatment strategies to enhance immune responses by using cytokines and checkpoint inhibitors in the macaque model and we have included CE DNA vaccine as part of a strategy to achieve immunotherapeutic remission.